Human Core

Project Summary/Abstract
Idiopathic pulmonary fibrosis (IPF) and chronic lung allograft dysfunction (CLAD) are disorders characterized
by the inexorable loss of lung function and death within 3-5 years of diagnosis. IPF and CLAD share features
of relentless extracellular matrix (ECM) deposition and the lack of response to immunosuppressive therapy.
Compelling preliminary evidence is presented in the 3 projects within this proposal that the progressive
scarring inherent to both IPF and CLAD is the consequence of dysregulated crosstalk between the lung
epithelium and the lung resident mesenchymal stromal cells. Although there are clear distinctions between
mechanisms of IPF and CLAD, this common theme should be investigated for potential therapeutic benefit in
each condition. Each of the 3 inter-related projects proposed in this application is strengthened by studies in
human subjects including the collection of patient specimens. We propose a Human Core to facilitate the safe
and efficient collection of research data and specimens from these human subjects. We will leverage access to
the large UCLA lung transplant program to supply high-quality human samples for the 3 program projects in
this application. Specifically, we will recruit and enroll 300 subjects listed for lung transplant, for any indication,
to participate in a post-transplant registry and bronchoscopy sample study proposed in Project 3. Among these
300 subjects, those with a diagnosis of IPF will be recruited to also provide their explanted IPF lung tissues for
Projects 1 and 2. All subjects will be entered into a registry and the samples will be linked to this robust
longitudinal database for clinical phenotyping. The Human Core comprises an experienced team of
investigators, clinical research staff and laboratory personnel who will support human subject research and
biological sample collection and processing for each of the 3 projects. This team has successful collaboration
across multiple projects during the past 5 years. Therefore, the combination of a high volume lung transplant
program, investigators' expertise, and an established infrastructure for human subject research and sample
collection, collectively amount to a one-of-a-kind resource to study IPF and CLAD.

Public health relevance
Project Narrative Future gains in understanding human lung fibrogenesis will be enhanced by studying high-quality patient- derived samples paired with carefully annotated clinical phenotypes and outcomes data. This Human Core will leverage access to a large lung transplant program, as well as our expertise with human subject research and biospecimen collection to support the research projects in this application. We believe this Human Core is crucial, feasible, and will help advance our understanding of mechanisms of both IPF and CLAD.